VIDEO FEEDBACK IN DRUG TREATMENT

Videotape feedback has been used as an effective technique in therapy for over 25 years. It is an important component of the job Seekers' Workshop (JSW), an approach to helping drug treatment clients become employed that has been shown to be effective in three controlled studies. The JSW Dissemination Project has successfully employed video feedback as a tool for training JSW group leaders in drug treatment programs. The purpose of the proposed research is to develop an effective program for training drug treatment professionals to use video feedback as a technique for helping their clients achieve treatment goals. The commercial application will be a fee-for- service training program which will have been demonstrated to be acceptable to participants and effective in developing skills in the use of video feedback as a treatment technique for substance abusers. In Phase I, a pilot training design and materials will be pilot- tested, evaluated, modified, re-tested, and re-evaluated. Evaluation will consist of pre- and post-training questionnaires, followup interviews, and review of practice videoptapes. The long term objective is to foster the use of videotape feedback techniques by professionals serving substance abuse clients, in many different settings.